Implementation and Translation Research Project Core

Overdose deaths occur at an alarming pace, particularly among those with criminal legal system (CLS)
involvement, and public health professionals continue to seek solutions to reverse this trend. Although empirically
supported prevention and treatment interventions for overdose and substance use disorders exist, and a rapidly
emerging evidence-based innovations became possible through JCOIN, tools for diffusing evidence-based
programs, policies, and practices beyond small-scale efforts are nascent. There is an urgent need for applied
models to support large-scale spread and scale-up of evidence-based innovations (EBIs) within criminal
legal/public health systems that can bridge knowledge translation between researchers and practitioners and
move beyond small-scale adoption of innovations. The Implementation & Translation Research Project (I-
Trans) Core will fill this need by creating and testing a model for EBI spread and scale-up for CLS agencies and
populations to promote the dissemination and implementation of life-changing strategies. The Implementation
Translation Spread and Scale-up Model (I-TranSS Model) will integrate conceptual underpinnings from several
other models, including the Consolidated Framework for Implementation Research; Diffusion of Innovation
Theory; and Knowledge Translation Complexity Network Model. Building on the experiences in JCOIN 1.0, the
team will pursue three new aims in JCOIN 2.0. Aim 1: Develop an implementation knowledge translation model
(I-TranSS Model). A key element of the Model is a Translation Spread and Scale-up Matrix, which will be
developed by the I-Trans Core, and designed for researchers and practitioners to use to select effective
dissemination and implementation strategies that will be applied based on inner and outer contextual factors.
JCOIN 1.0 researchers and HEAL researchers in CLS-related studies, research participants in JCOIN 1.0
studies, and other implementation experts will be key to the development of the I-TranSS Model. Aim 2: Generate
evidence about effective approaches to translate findings into practice while emphasizing conducting exploratory
research on elements of the I-TranSS Model. The I-Trans Core will use the Coaching Extender Platform
developed in JCOIN 1.0 and the dissemination and implementation of planned and emergent topics as a learning
lab to test key aspects of the I-TranSS Model, including the Translation and Scale-up Matrix. Aim 3: Implement
a methods component to document spread and scale-up using quantitative and qualitative methods and identify
measures suitable to foster knowledge of effective techniques. This activity will result in an inventory of
measurements and/or methods that researchers and practitioners can use to provide feedback on spread and
scale-up activities. The I-TranSS Model will be used to frame the design of future implementation research
projects. The I-Trans Core will provide opportunities for the participants of the Research Education Core (REC)
to gain experience conducting implementation research. JCOIN 1.0 and 2.0 will present opportunities to learn
about the most effective dissemination and implementation spread and scale-up efforts in JCOIN-related studies.